Dynamical Diffraction Analysis for 3D Electron Crystallography

Project Abstract
Diffraction methods generate detailed structural information for chemical compounds, driving discoveries in many
fields across academia and industry. The standard approaches use either single crystals, which provide highly
informative data, or powders of nanocrystals, which provide less information. Microcrystal electron diffraction
(microED) has all the data richness benefits of single crystal crystallography and works with small crystals.
However, the methods for microED data acquisition and analysis are not yet mature enough to provide results
with quality and reliability comparable to X-ray crystallography. The challenges include absolute configuration
determination, efficient data collection, and diffraction data analysis in the presence of microED-specific
experimental errors. In SBIR Phase I, we will develop, implement, and test methods that address handedness
determination for small molecule crystals and combine them with effective approaches to greatly reduce
systematic errors, to enable merging datasets from multiple crystals, experimental phasing and absolute
configuration determination. In SBIR Phase II, we will expand and incorporate these solutions into an easy-to-
use, complete crystallographic package for microED and also validate the approach in a broad range of
experimental conditions, tailoring the solutions to characteristic problems.
These new methods will benefit all types of microED analysis and result (1) in absolute configuration
determination for all type of compounds, (2) expanded applicability to radiation-sensitive and other difficult-to-
handle crystals, and (3) better agreement between the model and the data which will increase the trust in results,
in particular for de novo structure determination. These benefits are of high significance for this quickly expanding
field, so the potential for successful commercialization is high.

Public health relevance
Project Narrative Microcrystal electron diffraction (microED) can use micron and sub-micron crystals for structure determination, which are much easier to produce than the large crystals needed for the standard approach by X-ray diffraction. However, microED needs to be more robust and advanced to cover specific sub-problems of high interest, such as absolute configuration determinations. We will develop approaches producing and analyzing microED data to make the method widely used and applicable.